Mechanisms and Circumvention of Daptomycin Resistance in Streptococcus mitis

ABSTRACT
Viridans group streptococci (VGS), especially Streptococcus mitis, are pivotal pathogens in a variety of
invasive endovascular infections,including: i) “breakthrough bacteremias” and “toxic shock” in neutropenic
cancer patients; and ii) infective endocarditis (IE). Given world-wide trends in penicillin-resistance and other
β-lactam MIC “creeps” amongst S. mitis strains, the proportion of serious infections caused by relatively or fully
β-lactam-resistant-(R) strains is disturbing. Moreover, clinical outcomes in such cases utilizing alternate
regimens (e.g., vancomycin) have been disappointing, presumably related to the high prevalence of
vancomycin “tolerance” in such strains. This has prompted use of newer bactericidal agents, like daptomycin
(DAP) for severe S. mitis syndromes in strains with β-lactam-resistance. Alarmingly, recent recognition of
rapid, durable and high-level DAP-R induced by DAP therapy has significantly reduced enthusiasm for such
approaches. In addition, DAP MICs in the S. mitis group are 2-10-fold higher than all other VGS groups. The
number of reported clinical cases of invasive S. mitis infections in which DAP-R has emerged is limited, due to
the relatively infrequent use of DAP in such infections to-date. However, progressive rise in S. mitis β-lactam-R
plus the inconsistent outcomes of VANC therapy in such syndromes virtually assures increased DAP use,
leading to DAP-R S. mitis infections. Moreover, medical centers with high DAP usage have recently confirmed
substantial MIC “creeps” amongst enterococci. Understanding mechanism(s) of emergence of DAP-R in
S. mitis, plus strategies to circumvent its evolution are, thus, of great clinical significance.
Our Preliminary Data showed that DAP-R outcomes in S. mitis are likely to be multifactorial on both
phenotypic and genotypic levels. Most interestingly, we have now shown compelling evidence of two forms of
“DAP hyperaccumulation” in which individual cells in a given streptococcal chain can hyper-capture DAP and
either die (“altruistic suicide”) or resist DAP killing, in order to protect the remainder of the cell population from
DAP exposures and lethality. This is an apparently unique mechanism of DAP-R amongst gram-positive
pathogens.
In this proposal, we will use strategic fluorescence microscopy, flow cytometry with multidimensional
physiologic interrogations, and single cell sorting plus genotyping to divulge mechanisms by which DAP-R
S. mitis can resist DAP exposures. Finally, we will use two well-characterized models of endovascular
infections, ex vivo (chamber model) and in vivo (experimental rabbit IE), to define DAP regimens to both
circumvent emergence of DAP-R and enhance clearance of S. mitis. In summary, these studies will divulge
clinical strategies to forestall emergence of DAP-R in S. mitis and perhaps other Gram-positive pathogens.

Public health relevance
NARRATIVE Streptococcus mitis is an important cause of infections in cancer patients and those with heart valve infections. These strains are often resistant (R) to penicillins and cephalosporins, as well as new antibiotics like daptomycin (DAP). Understanding the mechanisms of emergence of DAP-R plus strategies to circumvent its evolution, while enhancing treatment, are our key goals.